Regulation of IgE production during aeroallergen sensitization

Project Summary/Abstract
Asthma is a debilitating lung disease marked by reversible airway obstruction that affects over 5% of the US
population and is growing in prevalence. In the majority of cases of asthma, allergic inflammation around the
bronchial airways contributes to disease pathogenesis. A key pathway in the initiation of allergic immune
responses is elicited by antibodies of the IgE isotype. In allergic individuals, IgE antibodies are produced with
specificity for components of harmless environmental substances, termed allergens. However, the mechanisms
responsible for the production of IgE specific for allergens inhaled into the respiratory tract (aeroallergens) remain
poorly characterized. One of the major limitations in understanding the process of allergic sensitization through
the respiratory tract has been technical difficulty in direct studies of IgE producing plasma cells and their B cell
precursors. My laboratory has developed methodology enabling the sensitive identification of these rare IgE-
expressing cells by flow cytometry and microscopy. The focus of this project is to apply this robust methodology
to study the generation of IgE-expressing cells following aeroallergen exposure through the respiratory tract. In
order to do a detailed analysis of tissues involved in respiratory tract immunity, we will study mouse models of
allergic airway disease. The overall objective of this project is to study the cellular response leading to the
production of IgE in allergic sensitization through the respiratory tract. The specific aims of this study are to: 1)
characterize the generation and fate of IgE B cells and plasma cells and their tissue localization in different
models of aeroallergen sensitization and 2) determine the relative abundance of allergen-specific IgE B cells and
plasma cells compared with other isotypes (IgM, IgG, and IgA) and establish their clonal relationships. The
results from these studies will provide important insights into IgE production after allergen exposure via the
respiratory tract. More broadly, this study will increase our understanding of the ways in which we may develop
sensitization versus tolerance to aeroallergens.

Public health relevance
Project Narrative Asthma is a disease of the airways that is growing in prevalence and represents a major public health burden. In the majority of people with asthma, IgE antibodies play a role in triggering allergic immune responses in the lung that contribute to disease pathogenesis. In this project, we will study how IgE responses to aeroallergens are initially generated, resulting in allergic sensitization.